Defining Campylobacter and immune response related determinants in the pathogenesis of Guillain-Barré syndrome patients in low-income countries

Project Summary
Since the eradication of poliomyelitis, Guillain-Barré syndrome (GBS) has become a major health
burden in low-income countries. The prognosis of GBS has not improved over the last two
decades. Our group previously showed that the incidence, disease severity and mortality of GBS
are higher in Bangladesh compared to the developed world. The preferred and most effective
treatment for severe GBS is intravenous immunoglobulin (IVIg), yet some patients respond
poorly to this recommended therapy. Little is known about the factors that influence disease
pathogenesis and recovery in patients receiving IVIg therapy in low-income countries. Our
long-term goal is to identify key determinants that predict IVIg treatment response in patients
with GBS from low-income countries. The main hypothesis of the proposed project is that
biological markers, nutritional factors or microbial strain differences may potentially influence the
response of IVIg or clinical course and outcome of patients with GBS in low-income countries.
Our objective is to identify key determinants to measure IVIg treatment responsiveness in
patients with GBS in Bangladesh. Our specific aims will test the following hypotheses: Specific
aim #1: We will identify whether biological markers serve as predictive factors to determine IVIg
treatment response or whether nutritional status affects IVIg treatment response, the clinical
course and GBS disease outcome in a low-income country. Specific aim #2: We will use high-
throughput sequencing to generate and compare the whole genome sequences of
Campylobacter jejuni strains isolated from IVIg-treated and non-treated patients with GBS, in
order to identify the key genetic determinants responsible for disease pathogenesis and
outcomes of IVIg treatment in low-income countries. The research proposed in this career
development application is built upon ongoing, long-standing collaborative efforts between the
icddr,b (Bangladesh), Erasmus University Medical Centre (the Netherlands), the University
of Texas (USA), Washington State University (USA) and the National Institute of Neurosciences
& Hospital (Bangladesh). The goal of this Career Development Program is to strengthen the
skills necessary to become an independent researcher/investigator in host-pathogen
interaction and advanced genomics research.

Public health relevance
Project Narrative: This research project will identify potential biomarkers, nutritional factors and microbial strain differences (using high-throughput sequencing) associated with the response of intravenous immunoglobulin (IVIg) treatment, as well as the clinical course and outcome of Guillain-Barré syndrome (GBS) in low-income countries. The proposed study will improve the understanding of IVIg treatment outcome and provide insight to guide the development of personalized medicine for patients with GBS. The project will involve extensive training activities and guidance from the mentors and training advisory group.